Genetics and Cell Biology Training Program

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
This is a new application to support a pre-doctoral training program in Genetics and Cell Biology at The Rockefeller University, an institution with a rich history in these scientific areas. The mission of the program is to provide trainees with the instruction, experience, and career development support needed for successful careers in genetics and cell biology. Objectives of the program include recruiting outstanding graduate trainees to the training program and providing them with comprehensive didactic training, state-of-the-art research skills, and professional skills needed for careers in the biomedical science workforce. Incorporated into the training plan are recurring training in responsible conduct of research and mechanisms to increase retention and reduce time-to-degree. We propose to support 12 pre-doctoral trainees per year in their second and third year of training: 6 in year two and 6 in year three. The applicant pool is outstanding, including many students with accomplished undergraduate records, extensive research experience and a strong interest in genetics and cell biology. The 49 faculty trainers are accomplished scientists, including 3 Nobel laureates and 19 members of the US National Academy of Sciences, with a shared interest and experience in graduate education. The interdisciplinary nature of the program encourages trainees to perform collaborative work in various areas with different faculty. Trainees would be mentored by the Program Directors; a Program Advisory Committee of selected faculty for general curriculum and research advice; and a Faculty Advisory Committee, specifically designed for each trainee to provide detailed experimental guidance. An External Advisory Committee will evaluate the effectiveness of the program and provide advice on new initiatives. Our past trainees have been highly successful, with most continuing in biomedical research careers. Upon completion, we expect trainees to have a range of scientific knowledge, technical expertise, and professional development skills necessary to become leaders in their chosen field.

Public health relevance
The proposed training program will support the training of predoctoral students in genetics and cell biology, with direct implications for human health and disease. The training includes clinically relevant coursework and research opportunities and will prepare trainees for a range of careers in the biomedical workforce.